Intelligent Information Systems for Systems Biology

DESCRIPTION (Provided by Applicant): Our Center will attack the challenges created by the large quantity of data generated from new high throughput technologies. We have teamed biologists, computer scientists and computational scientists from several Universities to build an experienced and distinguished team. Our first major tool building project will be an Object Oriented Framework for the integration of data and tools for genomics, proteomics, DNA arrays and protein-protein interactions. This tool will follow the data from the source through model building. It will build on existing open source tools such as a data acquisition package from particle physics (ROOT), a public database system (MYSQL or PostgreSQL), statistics tools ("R"), graphics libraries, a variety of software tools that have been developed at ISB and new tools needed for the new technologies. We stress the use of an open source system as a means to build the community, creating a functioning system that can be tailored for research and education. We then propose to augment this system with tools for analysis, visualization and model building. We will use yeast as a model system owing to the wide range of data that it available for it. Finally, we propose some novel educational programs designed to put graduate students together into interdisciplinary teams for problem solving.